Preventing Alcohol Use Disorders and Alcohol-Related Harms in Pacific Islander Young Adults

Abstract
Native Hawaiians/Pacific Islanders (NPI) in the U.S. are a rapidly growing racial group that suffers severe
alcohol-related disparities. In NPI communities, young adults (18-30 years) endure the greatest burden of alcohol
use disorders (AUD) and alcohol-related harms with our earlier NIAAA R21 study revealing that almost 50% of
community-dwelling NPI young adults are at heavy risk for, or have, AUDs with 40% experiencing alcohol-related
harms (e.g., health, social, work). Despite this, NPI young adults have received minimal alcohol research
attention, leading to a lack of effective interventions to prevent or reduce their extreme AUD risk.
Guided by the findings of our NIAAA R21, this resubmitted R01 study will respond to this public health gap
by refining and efficacy testing SPEAR (Strategies for Pacific Empowerment and Alcohol Reduction): a novel
culturally grounded AUD prevention intervention for NPI young adults. Building on our R21-developed Model of
SPEAR intervention components for NPI young adults (previously chosen and shaped in our R21 by NPIs from
existing AUD prevention interventions), in Aim 1, we will assemble our treatment manual from our NPI-shaped
R21 AUD prevention components. To assemble the manual, we will use our culturally congruent intervention
design methodology for NPIs involving an Advisory Council of community experts and citizens’ panels—an
innovative research approach that mirrors NPI collective decision-making practices—to obtain critical feedback
for refining SPEAR content/components from NPI young adults with high AUD risk and informal NPI providers.
In Aim 2, we will review and refine our treatment components and manual through expert review by 3 leading
alcohol research experts and feasibility pilot test the manual with 36 NPI young adults with high AUD risk for
feasibility, acceptability, and impact, using our findings to finalize SPEAR for our randomized controlled trial. In
Aim 3, we will test the efficacy of SPEAR by conducting a full-scale randomized controlled trial with 240 NPI
young adults with high AUD risk in two large NPI communities in Los Angeles County and Northwest Arkansas
for generalizability. Aligning with community research principles, we will share study findings with the NPI
community through public reports and presentations, and to the scientific community through academic
presentations and manuscripts.

Public health relevance
PROJECT NARRATIVE Native Hawaiian/Pacific Islander (NPI) young adults endure heavy alcohol-related disparities including high rates of hazardous drinking and alcohol use disorders that cause 40% of NPI young adults to suffer alcohol- related harms. Building on our intervention model of evidence-based alcohol prevention strategies selected and shaped in a prior NIAAA R21, this resubmitted R01 study will refine and then randomized controlled test SPEAR: a culturally grounded alcohol use disorder prevention intervention for NPI young adults. Using innovative community engaged research methods, this project will produce a first-of-its-kind culturally and community informed intervention to reduce alcohol use and prevent alcohol use disorders and harms in NPI young adults.